Determining the role of nuclear integrity loss surveillance in PARPi-inducedcell death in BRCA1-deficient cancer

PROJECT SUMMARY/ABSTRACT
Poly (ADP-ribose) polymerase inhibitors (PARPi) are synthetically lethal in cells with homologous
recombination (HR) defects, a phenotype of certain cancers. BRCA1 is one of the most commonly mutated
genes in hereditary, HR-deficient cancers. Unfortunately, patients with HR-deficient cancers commonly acquire
resistance to PARPi, and the mechanisms of PARPi-induced cytotoxicity are underexplored. Understanding
these pathways could provide insight into how patients acquire PARPi resistance. The PARPi cytotoxic
response requires cells to transit mitosis, and cells that persist through PARPi treatment (persister cells) arrest
from the cell cycle. Thus, determining this mechanism of cell cycle commitment is central to understanding
PARPi-induced cytotoxicity as cells face two potential fates in response to PARPi: undergo mitosis and trigger
cell death or arrest from the cell cycle and persist. My preliminary data suggests that arrested persister cells
have decreased levels of Lamin B1 (LMNB1, a nuclear lamina protein): loss of which is necessary and
sufficient to induce cell cycle arrest in other contexts. Thus, LMNB1 downregulation may contribute to the cell
cycle arrest mechanism in these persister cells. For PARPi-treated cells that undergo mitosis-dependent cell
death, the pathways governing this cytotoxicity are unclear. PARPi have been shown to synergize with other
drugs to induce various forms of regulated cell death (RCD) in different cell lines, suggesting that multiple
forms of RCD could be triggered in BRCA1-deficient cells. A systematic investigation is needed to determine
the RCD mechanisms involved in the PARPi response and the upstream regulatory pathways that initiate
them. One hypothesis of a contributing regulatory pathway is cyclic GMP-AMP synthase (cGAS) / stimulator of
interferon genes (STING) signaling, which canonically induces innate immune signaling in response to
cytosolic DNA. cGAS/STING signaling is increased in HR-deficient, PARPi-treated cells. Higher instances of
mitotic errors, including persistent DNA bridges, are also observed in response to PARPi treatment. As these
structures are prone to rupture, leading to loss of nuclear envelope integrity, we hypothesize that they could be
surveilled by cGAS to signal RCD in the PARPi response. The objective of this proposal is to determine the
mechanisms that confer vulnerability of BRCA1-deficient cells to PARPi-induced cytotoxicity. Using
BRCA1-deficient breast and ovarian cancer cell lines as models, in Aim 1 I will determine mechanism of cell
cycle evasion that allows cells to persist through PARPi treatment, specifically investigating LMNB1
downregulation as a contributing pathway. In Aim 2 I will conduct an arrayed CRISPR screen targeting RCD
driver genes and other regulatory pathways to determine the mechanisms of PARPi-induced cytotoxicity in
cycling cells, including investigating a role for cGAS/STING signaling. Overall, this proposal will enhance our
understanding of how cells evade or succumb to PARPi-induced cell death. This work could inform
combination therapies with PARPi to combat PARPi resistance in patients with BRCA1-deficient cancers.

Public health relevance
PROJECT NARRATIVE: PARPi are a common targeted therapy for patients with BRCA1-deficient cancer, but the mechanisms of PARPi-induced cytotoxicity remain elusive. This proposal will determine the cellular processes dictating whether cells exit the cell cycle to evade PARPi-induced cytotoxicity or commit to mitosis and succumb to cell death through mechanisms that will be investigated. The insights from this work could inform acquired PARPi resistance pathways and may reveal novel approaches to improve PARPi effectiveness.